MicroRNA regulation of chronic inflammation during aging

Abstract
Chronic inflammation, referred to as "inflammaging", is a risk factor for many age-related chronic conditions (e.g. diabetes, cancer, frailty). Aberrant immune responses may be linked to inflammatory-mediated metabolic and functional disorders but many mechanistic gaps exist. Among recently appreciated regulators of inflammaging are microRNAs (miRNAs). One example of which is the anti-inflammatory miR-146a, where we and others have shown that mice deficient in this miRNA succumb to a life-shortening chronic inflammation that involves clinically relevant comorbidities (1-6). Moreover, deletion of miR-155 in T cells significantly extends the lifespan of miR- 146a·1· mice which points to a vital role for T cell expressed miR-155 in this context including CD4+ T follicular helper (Tfh) cells (3, 5). We have recently expanded our analyses of this critical process by investigating novel pathways in aging T cells that are regulated by miR-155 during inflammaging. By conducting single cell RNA Sequencing (scRNA-Seq) we have identified three gene programs that are counter-regulated by miR-146a and miR-155 in aged T cells that have not been previously examined in this context. These include aerobic glycolysis, chemokine production, and senescence associated secretory phenotype (SASP) factors. Additional preliminary data stemming from initial exploration of these pathways have pointed us to a novel, age-associated inflammatory cos+ T cell subset (Taa cells) that is GZMK"CD8" and that expands in both mice and humans (7), and that is regulated by miR-155. Based on these preliminary data, we will carry out the following research aims in an effort to gain substantial new insights into T cell-dependent mechanisms that drive inflammaging and that are regulated by miRNAs. We will also uniquely extend these analyses to young and older adults in efforts to translate our findings to humans. 1) Determine the functional roles of miR-155-induced GZMK+CD8+ T cells during inflammaging. 2) Determine the molecular and metabolic mechanisms underlying miR-155 functions in T cells during inflammaging. 3) Determine if Taa and Tfh cells and their miR-155 levels in older adults correlate with markers of chronic, low-grade inflammation, insulin sensitivity, and muscle strength. We anticipate that this work will unveil key cellular and molecular mechanisms by which miRNAs play pivotal roles in regulating lifespan through their influence on T cell-mediated, age-dependent chronic inflammation. As a result, therapeutically actionable targets will emerge with the potential to limit age-associated human inflammatory diseases that continue to rapidly gain in prevalence in our society.

Public health relevance
Project Narrative Chronic, low-grade inflammation is a contributing factor to most diseases associated with aging. However, the molecular and cellular mechanisms that regulate chronic inflammation are still being deciphered. We will determine how specific regulatory microRNAs function to control age-dependent inflammatory status through their regulation of T cell metabolism, recruitment of inflammatory myeloid cells, and control of senescence-associated secretory phenotypes, and our work will identify novel therapeutic targets to treat this harmful condition.